INTERACTIVE ROLE OF INSULIN,GLUCOSE &AMINOACID--PROTEIN METABOLISM REGULATION

Examine the role that insulin, glucagon, epinephrine and norepinephrine play in regulating glucose and amino acid metabolism in man.